Ambystoma Genetic Stock Center

APPLIED RESEARCH COMPONENT - PROJECT SUMMARY
This component addresses the significance and need to generate new assays and approaches for disease
monitoring within the AGSC and beyond, and the need to generate and centralize information for diagnosing
and treating axolotl diseases. Next generation 16S rRNA sequencing will be performed to increase breadth of
pathogen monitoring and generate baseline microbial data in support of microbiome research, both of which
will better ensure the health and reproducibility of AGSC axolotl lines. Additionally, an axolotl disease manual
will be developed to provide a reference that axolotl labs can use to monitor pathogens and diagnose common
axolotl diseases. The manual will include protocols, assays, and treatments curated from the literature and
developed in house. Accomplishment of this sub aim will provide an essential resource for characterizing
lesions in diseased and genetically modified axolotls that serve as models of human disease.